Endothelialized microfluidic assays for emerging therapies in sickle cell disease

PROJECT SUMMARY
Sickle Cell Disease (SCD) afflicts 100,000 Americans and millions of people worldwide, and is characterized by
anemia, painful vaso-occlusive crises, ischemia, inflammation, significant morbidity, and early mortality. In SCD,
deoxygenated sickle hemoglobin (deoxy-HbS) polymerizes, deforms red blood cells (RBCs), changes
membrane properties, and triggers inflammation, thrombophilia, and vasculopathy. Traditional treatment
approaches include routine blood transfusions and hydroxyurea therapy while both options exhibit inherent
challenges and limitations. Recent efforts in developing new treatment approaches in SCD focused on targeted
therapies, aiming to prevent hypoxia-mediated polymerization of sickle hemoglobin and the abnormal adhesive
interactions between blood and endothelial cells. Accordingly, the Food and Drug Administration (FDA) has
recently approved two new treatments for SCD: ADAKVEO (Crizanlizumab, Novartis) and Oxbryta (Voxelotor,
Global Blood Therapeutics) to prevent abnormal RBC adhesion and sickling. In addition to those, many other
drug candidates targeting a specific adhesion pathway are currently in the development stage. Because SCD
pathophysiology is extremely complex and heterogenous, it is crucial to predict how/if a patient will benefit from
a specific targeted therapy. An anti-adhesive therapy may not benefit a certain patient population or may need
to be supplemented with additional therapeutic approaches (i.e., anti-sickling drugs). Further, patient-specific
responses to such therapies may be impacted by or associated with clinical variables (e.g., lactate
dehydrogenase level, reticulocyte count, hemoglobin levels, etc.). Being able to predict a patient's response to
a certain targeted therapy, or combination of multiple, using biomimetic in vitro tools will substantially help the
entire SCD patient population. Therefore, there is an urgent need for novel biomimetic in vitro assays that can
serve as a drug screening platform, both in understanding the effect of emerging therapies on a single patient
level and in screening drug candidates for potential mitigation of SCD pathophysiology.
Our objective in this STTR Phase I/II proposal is to develop a standardized and validated endothelialized
microfluidic cellular adhesion assay to predict in vitro patient-specific responses to a targeted therapy
by probing blood cell adhesion to activated endothelial cells. In Phase I, we propose to standardize and
validate the culture and activation of endothelial cells as well as blood cell adhesion within the Endothelium-on-
a-chip under physiologically relevant flow conditions. Phase II aims and milestones focus on activities related
to determining baseline cellular adhesion levels, establishing the testing methodologies for proof-of-concept, and
clinically validating the Endothelium-on-a-chip. Our goal is to demonstrate the utility of the Endothelium-on-
a-chip in predicting patient-specific responses to single and combined targeted therapies in SCD.

Public health relevance
PROJECT NARRATIVE We have recently developed an endothelialized microfluidic assay (Endothelium-on-a-chip), which was designed to provide a testing platform in a high-throughput manner, which can easily be translated into a commercial assay or product as a drug discovery/screening platform. The studies proposed in this application will advance the Endothelium-on-a-chip assay as a reliable, standardized, and validated commercial assay for accurate measurement of blood cell adhesion to endothelial cells under physiologic flow to assess modern targeted therapies, including hemoglobin modifying and anti-adhesive drugs. Overall, this translational project will allow predicting patient-specific responses to a certain targeted therapy, individualized monitoring following treatment, and potentially conducting highly informative pre-clinical assessments of novel therapies in SCD, with the Endothelium-on-a-chip being developed as personalized medicine tool.